Development and Sex Differentiation of Context Fear Neural Circuits

Understanding the post-natal emergence and progression of episodic/hippocampal based and
affective/amygdala based learning and memory systems in male and female animals can lead
to significant advances in education, anxiety disoders and a detailed understanding of neural
basis of learning and memory. We start off with the basic observation that learning and
memory in children and young animals are particulary distinct when compared to adult
mammalian counterparts. Our central hypothesis is that early in development, affective neural
circuits dominate learning and that later, cognitive neural circuits emerge to further regulate
learned behaviors. Moreover, the development and function of each these memory systems are
influenced by perinatal gonadal hormones, resulting in sex differentiation of learning and
memory.
This hypothesis is grounded in the knowledge that late maturing hippocampal and prefrontal
cortical circuits are fine-tuned to encode patterns of contextual-spatial elements and at test are
capable to sufficiently retrieve this same pattern of elements.This pattern completion view of
perceptual learning is combined with the knowledge that the basolateral and central amygdala
microcircuits emerge earlier in development and are crucial for emotional learning including
fear.
We approach these questions by using standard and modified Contextual Fear Conditioning
procedures in combination with neuroanatomical tools to create whole-brain functional neural
acitivity maps underlying learning and memory across developmental lifespan of the male and
female rat. These data will be used to create an open access database of all raw data,
functional maps and group analytics. In addition, these data will be used to target inactivation of
key neural pathways in the acquisition, retention and retriveal of contextual fear memories.

Public health relevance
PROJECT NARRATIVE Anxiety disorders afflict 18% of the U.S. population making it a significant mental health problem relevant to the NIH mission. Given this, the onset of anxiety disorders is most prominent in females, typically emerges around developmental periods of pre- adolescence and adolescence. With maladaptive fear and disrupted cognitive function being key features of anxiety disorders, unraveling behavioral and neural mechanisms in developing learning and memory systems can lead to a deeper understanding of anxiety disorders in males and females. Lastly, central to our approach and consistent with the NIH's blueprint for neuroscience, we will create and disseminate whole brain functional neuroanatomical maps of the developing contextual fear learning systems.